Daily and localized NSAID sonophoresis for symptomatic treatment of knee osteoarthritis

Project Summary: Osteoarthritis (OA) is the most common type of arthritis, affecting over 30 million adults in the United States in 2015 and represents over 25% of medical office visits according to the Centers for Disease Control and Prevention and the National Institutes of Health. Over 40% of individuals over 65 have symptomatic OA and reduced mobility due to the disease. OA pain is often mitigated with conservative treatment approaches such as water therapy, walking, cycling, and pharmaceuticals. Regular use of NSAIDs can have adverse side effects on cardiovascular, gastrointestinal and renal systems. As such, topical NSAIDs are often used and provide similar pain relief to oral NSAIDs. Long-duration ultrasound has been used to reduce pain and improve joint function in patients with knee OA. When ultrasound is used in conjunction with topical pharmaceuticals, sonophoresis drives the molecules deeper into tissue, providing improved pain relief compared to ultrasound alone or topical application of NSAIDs alone. This proposal will develop and evaluate a sonophoresis patch that couples with a long-duration, low-intensity ultrasound wearable device. This battery powered, wearable sonophoresis patch can be self-applied and administers ultrasound through novel NSAID enriched hydrogel coupling patch for extended treatment durations, driving NSAIDs deeper into tissue and providing superior pain relief to topical NSAIDs or ultrasound alone. Key Features of the Proposed Work: (1) First ZetrOZ Systems, LLC will design and evaluate a sonophoresis coupling patch, enriched with NSAIDs (piroxicam 0.5%). Critical ultrasound coupling specifications will be evaluated under bench testing conditions including thermal properties and acoustic coupling. (2) ZetOZ Systems, LLC will assess human factor engineering considerations. A sample of 20 participants will be instructed how to apply the sonophoresis patch and ultrasound device to the OA affected knee during a 10-minute demonstration. Then, participants will apply the sonophoresis patch for five treatment sessions of four hours, with a maximum of one treatment session per day. All five treatment sessions will be performed within a 7-day period. After each treatment session participants will fill out a questionnaire relating to the ease-of-use, repeatability, mobility limitations, or otherwise adverse effects. Human factors considerations are an integral factor in the design process and any necessary changes will be implemented prior to clinical efficacy studies following this project. (3) An 8-week, 50 patient, double-blind randomized clinical efficacy pilot study will be conducted to evaluate the sonophoresis patch compared to long-duration ultrasound treatment. The primary outcome of the study will be pain score, evaluated daily using the numerical rating scale (NRS). Baseline NRS score will include the first two weeks of the study without intervention. Intervention phase will separate two demographically equivalent groups of 25, assigned to use either the sonophoresis or standard gel coupling patch with daily self-applied ultrasound treatment for six weeks. The proposed combination therapy has the potential to deliver a safe, effective, and conservative treatment approach for OA in the aging population.

Public health relevance
Project Narrative: This project proposes to develop and evaluate the first home-use NSAID-enhanced sonophoresis patch for use by an aging population with osteoarthritis. We will finalize development of the ultrasound-based drug delivery system, and evaluate the sonophoresis patch in human factor study and pilot clinical trial on knee osteoarthritis.